Global Center on Climate Change and Water Energy Food Health Systems - Community Engagement Core

COMMUNITY ENGAGEMENT CORE ABSTRACT
The Community Engagement Core (CEC) will be a central part of Center activities and will work closely with the
Research Project team, and the Administrative and Data Services cores to ensure equitable and ethical
involvement of community stakeholders in the implementation of the proposed interventions. The exploratory
efforts of the proposed Global Center on Climate Change and Water Energy Food Health Systems (GC3WEFH)
will target vulnerable communities (i.e., farming villages and refugee camps) living in the Azraq Basin region of
Jordan that are experiencing drastic impacts on their water resources due to the effects of climate change. The
rural agricultural communities we target suffer from poverty and are in a similar geopolitical situation as many of
the low-to-middle income countries that will be impacted the most by climate change. The goal of the CEC is to
not only facilitate access to these communities, but to involve local residents in the development of solutions so
that interventions will meet the actual needs of targeted communities and be more likely to succeed in improving
health outcomes. Importantly, communities will be partners, rather than just participants, in the proposed
research and the evaluation of outcomes. To accomplish this goal and evaluate water and sanitation issues at
the Water Energy Food Health (WEFH) nexus, the CEC will work with seven different local Jordanian
organizations in multiple stages of engagement, including formation of a stakeholders’ advisory board and use
community-based participatory research to pursue the following specific aims: 1) Establish an outreach plan to
bring community partners together to work under the umbrella of the Center. 2) Initiate multidirectional engaged
communication and education between the communities of farmers, youth, refugees, as well as public officials
with Center researchers, focused on the scientific background of climate change and its direct and indirect health
impacts. This will advance data literacy in the target communities as they relate to climate change. 3) Translate
findings from publicly available data and the Center’s research project component into meaningful applied ideas,
interventions, and actions that the community can implement. 4) Implement feasible policies and interventions
driven by the scientific findings and initiated by the needs of the community. 5) Evaluate the impacts of these
activities and actions in terms of the level of community engagement, feasible actions, and elevated knowledge
about the problem and potential solutions. Successful engagement with the community and achievement of
these aims will serve to galvanize and empower community stakeholders in using data analysis and mapping
tools to help address significant regional environmental challenges, while also creating a network of water
advocates who will serve to engage the wider community for future research undertaken by the GC3WEFH.